Role of Th1 Immune Responses in the Pathogenesis of Hypertensive Kidney Injury

DESCRIPTION (provided by applicant): The renin-angiotensin system (RAS) plays a key role in the pathogenesis of chronic kidney injury. Clinical trials with RAS inhibitors suggest angiotensin II (Ang II) may promote renal injury through blood pressure- independent effects. Activation of the immune system by the RAS has been suggested as one mechanism mediating these actions. We have found that chronic infusion of Ang II causes significant kidney injury, infiltration of CD4+ T helper lymphocytes into the kidney, and enhanced expression of pro-inflammatory cytokines including interferon-g (IFN-g) and tumor necrosis factor-a (TNF-a). Administration of the broadly acting immunosuppressive agent mycyophenolate mofetil (MMF) abrogated these effects without affecting blood pressure. Accordingly, we hypothesize that activation of a CD4+ T cell-dependent cellular immune response by Ang II contributes to chronic kidney damage in this setting. Typically, CD4+ T cells do not directly mediate cytotoxic tissue injury. Rather, they regulate immune responses by differentiating into type 1 (Th1) or type 2 (Th2) CD4+ T helper cells. Whereas Th2 cells regulate antibody responses, Th1 cells secrete IFN-g leading to activation of macrophages and cytotoxic CD8+ T cells to mediate cellular damage. Activated macrophages in turn produce TNF-a, which further stimulates Th1 cells. We therefore suggest that Ang II acting through type I angiotensin (AT1) receptors promotes the development of a Th1 immune response in the kidney, with enhanced production of IFN-g and TNF-a leading directly to progressive kidney disease through blood pressure-independent mechanisms. To test this, we will examine Ang II-induced kidney injury in mouse lines with genetic modifications impacting: transcription factors critical for Th1 differentiation, key Th1 cytokines, and AT1 receptor responses in key cell lineages. In addition to CD4+ T cells, IFN-g and TNF-a are expressed by several immune cell lineages and even by renal parenchymal cells. Therefore, we have designed experiments to identify the cellular sources of these cytokines in Ang II- dependent kidney injury. Understanding how Th1 immune responses influence Ang II-induced renal damage should lead to more effective strategies for preventing progressive chronic kidney disease.

Public health relevance
PUBLIC HEALTH RELEVANCE: Hypertension is a common cause of chronic kidney disease. This proposal explores how activation of a subset of T lymphocytes (Th1 cells) leads to kidney injury in angiotensin II-dependent hypertension. Understanding how Th1 immune responses influence angiotensin II-induced renal damage should lead to more effective strategies for preventing progressive chronic kidney disease. Hypertension is a common cause of chronic kidney disease. This proposal explores how activation of a subset of T lymphocytes (Th1 cells) leads to kidney injury in angiotensin II-dependent hypertension. Understanding how Th1 immune responses influence angiotensin II-induced renal damage should lead to more effective strategies for preventing progressive chronic kidney disease. __SpecificAimsTextDelimiter__ The renin-angiotensin system (RAS) plays a key role in the pathogenesis of chronic kidney injury. Clinical trials with RAS inhibitors suggest angiotensin II (Ang II) may promote renal injury independent of its effects on blood pressure. Activation of the immune system by the RAS has been suggested as one mechanism mediating these actions. For example, we have found that chronic infusion of Ang II causes significant kidney injury, infiltration of CD4+ T helper lymphocytes into the renal parenchyma, and enhanced expression of pro- inflammatory cytokines including interferon-J (IFN-J) and tumor necrosis factor-D (TNF-D). Administration of the broadly acting immunosuppressive agent mycyophenolate mofetil (MMF) abrogated these effects without affecting blood pressure. Accordingly, we hypothesize that activation of a CD4+ T cell-dependent cellular immune response by Ang II contributes to chronic kidney damage in this setting. Typically, CD4+ T cells do not directly mediate cytotoxic tissue injury. Rather, they control immune responses by generation of prototypical patterns of cytokines. This involves genetic programming and differentiation into one of two T- helper (Th) phenotypes: type 1 (Th1) or type 2 (Th2) CD4+ cells. Whereas Th2 cells regulate antibody responses, Th1 cells secrete IFN-J leading to activation of macrophages and cytotoxic CD8+ T cells, which mediate cellular damage. In an escalating inflammatory cycle, activated Th1 cells and macrophages also produce TNF-D, which further stimulates tissue injury. We therefore suggest that Ang II acting through type I angiotensin (AT1) receptors promotes the development of a Th1 immune response in the kidney, with enhanced production of IFN-J and TNF-Dleading to progressive chronic kidney disease through mechanisms that are independent of blood pressure. To test this hypothesis, we will use mouse lines, some of which have been generated in our laboratory, with genetic modifications impacting: transcription factors critical for Th1 differentiation, key Th1 cytokines, and AT1 receptor responses in key cell lineages. Using a model of Ang II- dependent proteinuria and kidney injury that has been well characterized in our laboratory, we will test the consequences of eliminating these key pathways. In addition to CD4+ T cells, IFN-J and TNF-Dare expressed by several immune cell lineages and even by renal parenchymal cells. Therefore, we have designed experiments to identify the cellular sources of these cytokines in Ang II-dependent kidney damage. We suggest that the Th1 cytokine network is a final common pathway promoting hypertensive kidney injury. Understanding the nature and characteristics of this pathway should lead to more effective strategies for preventing progressive chronic kidney disease. SPECIFIC AIM 1: To establish the contribution of Type 1 (Th1) helper T cell responses in hypertensive kidney disease. Tbet is a transcription factor that is absolutely required for differentiation of Th1 helper T cells. Accordingly, Tbet-deficient mice are unable to generate effective Th1 responses. Thus, to directly address the role of the Th1 response in hypertensive end-organ damage, we will compare the pattern and extent of Ang II-induced kidney injury in Tbet-deficient mice and wild-type controls. Our hypothesis predicts that hypertensive kidney damage will be ameliorated, and expression of IFN-J and TNF-D will be attenuated in Tbet-deficient animals. SPECIFIC AIM 2: To determine the relative contributions of individual Th1 cytokines to chronic kidney damage. In a Th1 immune response, tissue damage is accomplished through generation of pro- inflammatory mediators, including IFN-J and TNF-D. In this regard, we find that expression of IFN-J and TNF- D are prominently enhanced during hypertensive kidney disease. We therefore hypothesize that generation of these cytokines represents a critical pathway in the development of proteinuria and kidney injury. We will use mice lacking TNF-D or IFN-Jto determine their contribution to hypertensive kidney damage and we predict that the absence of IFN-J or TNF-D will be protective in our model of Ang II-dependent hypertension. There are a number of cell lineages in addition to CD4+ Th1 cells capable of generating IFN-J and TNF-D in our model. Accordingly, if renal disease is attenuated in mice with global deficiency of IFN-J or TNF-D, we will examine the specific cellular sources of these cytokines using bone marrow transfers and renal cross- transplantation. SPECIFIC AIM 3: To examine whether direct activation of AT1 receptors on CD4+ T cells is sufficient to generate a Th1 response. Differentiation of Th1 cells typically involves complex interactions between CD4+ T cells and antigen-presenting cells in the appropriate cytokine milieu. We hypothesize that activation of AT1 receptors on CD4+ T cells promotes this response. To determine the role that direct activation of AT1 receptors on T lymphocytes plays in stimulating renal expression of Th1 cytokines, we have generated mice with cell-specific deletion of the AT1A receptor in T lymphocytes using Cre-loxp techniques. We anticipate that AT1 receptor deficiency on T cells will mitigate Th1 patterns of kidney injury in hypertension.